GeNYC: Genomic Implementation Research in the Diverse Settings and Populations of New York City

Project Summary
The promise of genomic medicine to transform healthcare and improve health will not be fully realized
until discoveries become relevant to and available for use by diverse populations and their clinicians.
As part of the IGNITE II network, we are implementing two prospective randomized pragmatic
genotype-guided clinical trials (GUARDD-US and ADOPT-PGx) to determine the impact of
implementing genetic testing on hypertension, depression, and pain therapies. This administrative
supplement request is to extend the implementation timeline for these two pragmatic clinical trials by
an additional 12 months with cost to allow for completion of GUARDD-US and ADOPT PGx data
analysis, writing up of study results and closeout of all study activities. We expect the successful
results from this clinical trial will provide critical evidence needed to drive the implementation of
genomic medicine across broad demographics of patient populations.

Public health relevance
Project Narrative GUARDD-US: People with African ancestry (AAs) have the highest rates of uncontrolled high blood pressure, chronic kidney disease and kidney failure, due in part to APOL1 genetic variants nearly exclusively found in AAs that increase risk of kidney failure up to 10-fold. We will test AA adults with high blood pressure for APOL1 and return the results to patients and their clinicians, to see if early knowledge of high genetic risk improves blood pressure, provider and patient behaviors and is cost effective. ADOPT PGx: Certain genetic variations have been shown to cause poor, intermediate or ultra-rapid of commonly prescribed opioid and SSRI medications, thus genotype guided prescribing like that proposed in this study has the potential to greatly improve treatment and quality of life for patients with pain and depression.